METABOLIC SYNDROME IN AN ELDERLY POPULATION IS MORE LINKED TO INSULIN RES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this research study is to identify obese elderly people who are at risk for blood vessel disease. Approx 156 subjects will be recruited.